National Implementation of FOYC+CImPACT in the Bahamas: implementation strategies and improved outcomes.

Project Summary/Abstract
Over the past two decades, the Bahamian Ministries of Education (MOE) and Health (MOH) and our research
team have adapted a CDC “Best Evidence” HIV Prevention Program to produce the “Focus on Youth in the
Caribbean (FOYC) and Caribbean Informed Parents and Children Together” (CImPACT) risk reduction
program to address the HIV epidemic in The Bahamas. Two randomized, controlled longitudinal trials of FOYC
and FOYC+CImPACT found the programs to be effective in improving knowledge, condom-use skills and/or
self-reported risk behaviors. In 2010 the MOE decided to include FOYC (logistically less complex than
FOYC+CImPACT) in the government grade-6 curriculum nationwide, with boosters in grades-7 and -8. The
MOE now plans to expand the offering to the more effective but logistically more complex FOYC+ CImPACT
version. The MOE, MOH and our research team examined factors associated with fidelity of teaching FOYC
among 283 teachers, and the relationship between fidelity of teaching with student outcomes among 4,411
students. Teachers taught slightly over 50% of FOYC's core activities. Evaluations indicate that students taught
by “low-performing” teachers exhibited poorer outcomes in HIV/AIDS knowledge, condom-use skills, self-
efficacy, and intentions; the reverse was true for students of “high-performing” teachers. Screening
instruments and tracking processes to identify teachers at risk of low implementation, and evidence-based
implementation support and remediation programs have been identified/developed for use throughout
implementation. Biweekly “real-time” data-gathering and analysis to inform ongoing decision-making about
adjustments or changes to be made to the implementation plan of FOYC+CImPACT by the MOE and MOH are
the focus of this proposal. A Bahamian-specific adaptation of communities of practice (CoP), implementation
monitoring and feedback, and innovative training are strategies to enhance teachers' implementation. The
proposed research addresses three hypotheses of public health importance: 1. A more intensive training and
supervision program for at-risk or moderate-performing teachers will enhance their implementation fidelity to
the average level of the high-performing group (85%); 2. An HIV-prevention program delivered at the national
level can be a) implemented with fidelity (delivering >85% of core activities in both FOYC and CImPACT
consistent with that described by the developers) in grade-6; and, b) sustained over time (monitored annually);
and, 3. Student outcomes (knowledge, reproductive health skills, perceptions and self-reported behaviors) will:
a) continue to be highly correlated with implementation fidelity; and, b) be sustained over time (assessed
annually through grade 9). We aim to determine if the provision of either or both a) biweekly monitoring,
feedback and support through a “community of practice” to at-risk and moderate-performing teachers; and b)
an enhanced decision-making platform by the MOE and MOH based on the real-time implementation data
will: 1) increase national implementation fidelity; and 2) result in sustained implementation over time.

Public health relevance
Project narrative/public health impact The global public health impact of the HIV/AIDS epidemic is unparalleled in the last half-century. Currently the global public health community is at a critical juncture, working towards the possibility of eradicating the global AIDS epidemic by the year 2030. However, this excitement is tempered by mounting concern that if this goal is not achieved, emerging resistant HIV strains and declining resources targeting the problem may result in a resurgence of the epidemic. The proposed research will support the efforts of the entire nation of The Commonwealth of The Bahamas and serve as a prototype for other nations in the quest for elimination of the HIV/AIDS epidemic by 2030. It employs a theory-based, practical, data-driven implementation process to deliver an evidence-based HIV prevention curriculum through the government school system to all students throughout the nation enrolled in grades-6 to 9 and their parents.